Host Immunity Against Bacteria

We are interested in how bacteria and bacterial products shape the development of subsequent innate and adaptive immune responses with the goal of understanding how these host-microbe interactions influence pathogenesis of infections, autoimmunity, allergy, and cancer. Our previous work has shown that cholera toxin, a mucosal adjuvant and the agent responsible for the diarrhea caused by Vibrio cholera, induces a Th17 response characterized by CD4 T cells that secrete IL-17. In 2009, we have established that this induction of Th17 cells is critical for the protective adjuvant effects of cholera toxin in a novel vaccine against a murine model of inhalation anthrax. We have also explored the mechanisms involved in induction of this Th17 response, identifying novel pathways in dendritic cells and T cells that contribute to differentiation of naive T cells into Th17 cells. These studies enhance our understanding of the mechanisms controlling T cell differentiation and identify potential pathways that can be targeted to enhance vaccine efficacy against cancer and infectious diseases.